Effect of Expanding Barrier Precautions for Reducing Clostridium difficile Acquisition in VA.

Background: Each year approximately 1.7 million occur in the United States causing significant morbidity and
nearly 100,000 deaths. Clostridium difficile infection (CDI) has become the most common healthcare-
associated infection (HAI) in U.S. hospitals causing half a million infections and 30,000 deaths. CDI ranges
from asymptomatic colonization, mild to severe diarrhea, pseudomembranous colitis, toxic megacolon, colonic
perforation, and death. Risk factors for CDI include older age, comorbidity, hospitalization, exposure to others
with CDI, and antibiotic use. The increasing incidence of C. difficile and emergence of new epidemic strain has
resulted in outbreaks in healthcare settings. Prevention of healthcare-onset (HO) CDI has quickly become a
priority for most hospitals. Hospital prevention measures are limited to modifiable risk factors (i.e., prudent
antibiotic use and limiting exposure to C. difficile). Hospital exposure to C. difficile can occur directly (i.e.,
hands or clothing of healthcare workers) or indirectly (i.e., environmental surfaces or shared equipment) so
infection prevention measures focus on healthcare worker hand hygiene, healthcare worker barrier precautions
(i.e., use of gowns and gloves) and cleaning and disinfection of the hospital environment and reusable medical
equipment. However, these interventions are limited to symptomatic patients who test positive for CDI.
Asymptomatic patients serve as a reservoir for cross contamination, but microbiological screening for
asymptomatic carriage of C. difficile is not routinely performed in healthcare. Gloving for all patient contacts
may interrupt transmission from asymptomatic patients colonized with C. difficile.
Objectives: The overall purpose of the proposed study is to determine the effectiveness of healthcare worker
use of gloves for all patient contact for reducing acquisition of C. difficile and hospital-onset CDI in inpatient
hospital units. The main objective of the study is to compare the effects of universal gloving for all patient
contact to the current standard of care (i.e., glove and gown only for known CDI cases). The specific aims are
1) Compare the effects of universal gloving for all patient contact to the current standard of care on C. difficile
acquisition rates in hospitalized patients; 2) Compare the effects of universal gloving compared to standard of
care gloving on CDI rates, other healthcare-associated infections, 30-day mortality and unit length of stay; 3)
Evaluate intervention fidelity, the cost and stakeholder experiences.
Methods: The study will be a cluster randomized trial (CRT) in ten inpatient VA hospital units. In the pre-
intervention period we will conduct preparatory work including recruiting hospitals, training research assistants,
securing IRB approval, identifying current practices, finalizing monitoring and observation plans and measuring
baseline C. difficile acquisition rates. This will be followed by an intervention period executing the CRT in which
hospital units will be randomized either to implement barrier precautions for all patient contacts or continue
standard care (i.e., barrier precautions for patients with known CDI). The intervention will consist of all
healthcare workers (nurses, providers, respiratory therapist, radiology and laboratory technicians, etc.) utilizing
gloves for all patient contacts in the units that are randomized to receive the intervention. The non-intervention
units will follow standard of care which consists of healthcare workers following barrier precautions (i.e., gloves
and gowns) only for patients with known CDI and other antibiotic-resistant organisms (e.g., MRSA). The unit of
analysis is the ICU, since data are collected at the level of the unit. Monthly data will be collected from all
participating sites including C. difficile acquisition and infection rates, mortality, length of stay, barrier
precaution compliance and end-user perceptions.
Impact: The anticipated impact on Veterans’ healthcare is primarily the reduction of C. difficile acquisition and
subsequent infection and its associated morbidity, mortality and costs. If found to be effective, the results will
change the paradigm for CDI prevention in healthcare settings.

Public health relevance
Clostridium difficile is a major pathogen causing serious healthcare-associated diarrheal illness in veterans. Prevention of healthcare facility-onset of C. difficile infection (CDI) is essential. A significant proportion of CDI is caused by transmission of the pathogen from asymptomatic colonized patients. However, data on interventions focusing on colonized patients are sparse. Universal gloving by healthcare workers for all patient contacts may reduce CDI. The work proposed will examine the effectiveness of universal gloving versus standard of care in a cluster randomized trial for preventing C. difficile acquisition and CDI, the results of which will inform infection control measures for CDI prevention throughout the VA.